A preconception cohort study on oil and gas development, fertility, and pregnancy

PROJECT ABSTRACT
Residential segregation is the geographic separation of low income and historically marginalized individuals into
distinct environments. For many U.S. residents, residential segregation serves as both a reflection and
reinforcement of structural racism. Although residential segregation has been identified as a root cause of
disparities in the U.S., long-term consequences of residential segregation remain largely understudied, including
environmental and reproductive consequences such as the racist siting of hazardous industries (e.g., oil and gas
development [OGD] sites) and fertility (fecundability, the per-cycle probability of pregnancy). OGD activities are
rapidly expanding across North America and projected to continue through 2032, many of which are
disproportionately sited in marginalized or racially devalued communities. OGD activity also poses a significant
threat to reproductive health, which may be amplified in segregated neighborhoods (an environmental framework
known as “fossil fuel racism”). Epidemiologic research also indicates residential segregation influences health
outcomes across the reproductive continuum, which may be modified by environmental hazards given racialized
economic patterns of (dis)investment, however its impact on fecundability is not known. In this application, we
evaluate environmental and reproductive consequences of residential segregation during the preconception
period. We will use prospective cohort data from Pregnancy Study Online (PRESTO), a North American
preconception cohort study, which is the largest and most diverse preconception cohort in existence (n>15,000
U.S. participants). PRESTO has remarkable geographic, racial, and socioeconomic diversity, with participants
enrolled across all 50 U.S. states, and >20% of participants identify as Black, Indigenous, or People of Color
(BIPOC). Reproductive-aged couples are recruited and followed for up to 12 months or until pregnancy using
internet-based methods, and a wealth of data are collected that makes PRESTO uniquely suited to evaluate
complex influences of residential segregation. We will use these data to address the following aims: 1)
characterize exposure to residential segregation, 2) estimate the effect of residential segregation on the
prevalence of OGD sites in disadvantaged neighborhoods, and 3) estimate the effect of residential segregation
on fecundability, including effect modification by OGD activity. This diversity supplement will also support Ms.
Sharonda Lovett’s training to build and strengthen skills to achieve her long-term career goal. Under the
mentorship of Dr. Mary Willis (an expert in geospatial exposure assessment, applied data science, and
environmental exposures), this diversity supplement will support Ms. Lovett (the candidate), develop expertise
in geospatial exposure assessment and environmental epidemiology, both of which are areas she has not had
formal training to date. The tailored career development plan involves coursework, intensive workshops, and
didactic experiences overseen by an interdisciplinary team with an excellent track record of collaboration and
mentoring to ensure that Ms. Lovett gains well-rounded training.

Public health relevance
PROJECT NARRATIVE Residential segregation, one example of structural racism, has long been recognized as a root cause of disparities in the U.S. and imposes inequitable burden on marginalized communities. The proposed project aims to assess the extent to which residential segregation influences oil and gas development and fertility among couples attempting pregnancy, which will be the first to characterize and evaluate residential segregation during the preconception period. This work seeks to identify opportunities for environmental and reproductive intervention, which will inform the development of targeted interventions to improve population health.